Functional and Molecular Dissection of Mutant Calreticulin in Myeloproliferative Neoplasms

PROJECT SUMMARY
Although the mechanism by which calreticulin (CALR) mutations cause myeloproliferative neoplasms (MPN) has
been elucidated, there is currently a fundamental gap in translating this knowledge into innovative therapeutic
strategies. The long-term goal is to advance the treatment of CALR-mutant MPN, in particular to develop new
therapies with disease-modifying activity and curative potential. The overall objective in this application is to
exploit the insights we have gained from understanding the altered biochemical properties and unique molecular
dependencies of mutant CALR-driven MPN, to identify novel therapeutic vulnerabilities, including in the context
of CALR/ASXL1 co-mutation. The central hypothesis is that CALR-mutant hematopoietic stem cells (HSC)
have unique properties, which arise as a consequence of the mechanism of oncogenicity of mutant CALR, which
we have previously elucidated. The specific properties, which we hypothesize that CALR-mutant HSC possess,
include altered protein homeostasis and a differential dependency on key cellular pathways (e.g. N-glycosylation
and protein secretion) for survival. We further hypothesize that co-operating genetic events (e.g. concomitant
ASXL1 mutation) alter the chromatin state of CALR-mutant HSC to drive disease progression in MPN. The
rationale for the proposed research is that, once we develop novel therapeutic strategies to target the unique
properties of CALR-mutant HSC, we will be able to preferentially target CALR-mutant MPN cells in patients. This
has the potential to alter the natural history of CALR-mutant MPN, including in the context of ASXL1 co-mutation,
which confers a negative prognostic impact on CALR-mutant MPN. Guided by strong preliminary data, the
hypothesis will be tested by pursuing three specific aims: 1) Determine protein homeostasis and sensitivity to
proteasome inhibition in Calr-mutant HSC; 2) Determine the molecular vulnerabilities of mutant CALR-driven
MPN; and 3) Determine the impact of mutant Asxl1 on Calr-mutant MPN in vivo. Under the first aim, a mutant
CALR knockin (KI) mouse model that closely recapitulates the features of human CALR-mutant MPN will be
employed to measure protein synthesis and proteasome activity in Calr-mutant HSC and to determine if Calr-
mutant HSC are differentially sensitive to in vivo proteasome inhibition. Under the second aim, key cellular
pathways we have found to be uniquely required for the survival of mutant CALR-expressing hematopoietic cells
in an in vitro whole genome CRISPR knockout screen, will be inhibited using functional genetic and
pharmacological approaches in mutant CALR KI mice. Under the third aim, the impact of mutant Asxl1 on histone
modifications, chromatin state and the transcriptome of Calr-mutant HSC, will be determined using a mutant
Asxl1 KI mouse. The approach is innovative through the application of novel murine models, in vitro and in vivo
CRISPR/Cas9 gene editing, chemical screening and mass spectrometry (MS)-based quantitative proteomics.
The proposed research is significant because it will uncover novel therapeutic vulnerabilities in CALR-mutant
MPN. Ultimately, such knowledge has the potential to be transformative in the treatment of this disease.

Public health relevance
Narrative The proposed research is relevant to public health because it will identify new approaches to treating a group of blood disorders called myeloproliferative neoplasms (MPN), that arise due to mutations in the gene, calreticulin (CALR). MPN is characterized by excess blood cell production, an increased risk of blood clotting and bleeding, in addition to increased risk of transformation to acute leukemia and no curative treatment options apart from stem cell transplantation. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to understanding mechanisms of disease with the goal of identifying better, more specific treatment options, thus reducing the burden of human disease.